Leadership Training in Real-World Data Analytics: Sleep and Alzheimer's Disease

ABSTRACT
In the past decade, there has been an explosion in availability of real-world data (RWD). With RWD’s vast
potential, there is a need for scientists with the training to lead multidisciplinary teams to generate insights from
such data and translate them into population health improvements. In August 2022, I was awarded my first R01,
which seeks to determine the impact of sleep apnea treatment on the risk for cognitive decline and Alzheimer’s
disease and related dementias (ADRD). While I have been fortunate to achieve “research independence,” I need
leadership training to catapult into a mid-career scientist with a broader NIH-funded research program. The
purpose of this proposed K02 award is to support my transition into a multiple R01-funded researcher and
establish leadership in using RWD to advance sleep health and Alzheimer’s disease prevention both locally at
the University of Florida (UF) and nationally. In pursuit of this goal, I have designed a 5-year comprehensive
leadership development program to provide the needed training and resources to develop key skills needed for
the next stage of my career: a) obtaining a better understanding of RWD methodologies, b) gaining leadership
skills for managing interdisciplinary research teams and collaborations, and c) establishing a Sleep Research
Collaboratory at UF focused on sleep, Alzheimer’s disease, and RWD. The planned leadership training is
specifically designed to capitalize on the extensive RWD resources available to us at the University of Florida,
including an extensive database of both public and private healthcare claims, and notably OneFlorida+, a large
PCORI-funded research network that includes a data trust of electronic health records from almost 19 million
patients in the Southeast. Leveraging resources and collaborations at UF, I will conduct research to generate
preliminary data supporting two R01 submissions to understand the impact of glucagon-like peptide-1 receptor
agonists (GLP-1 RAs) on cognitive outcomes in patients with sleep apnea. Recent research has indicated GLP-
1 RAs as a promising treatment for sleep apnea, making it crucial to explore their effects on cognition. The first
proposal will be a competing renewal of my R01 focusing on understanding if treating OSA with GLP-1 RAs can
slow cognitive decline and, ultimately, ADRD. A second new R01 will propose to conduct an emulated clinical
trial in OneFlorida+ to investigate the impact of GLP-1 RAs on the treatment of OSA and cascading cognitive
outcomes. The leadership training I propose, alongside the collaborations I will build for these R01 submissions,
will directly contribute to developing a research community at UF focused on sleep research and ADRD using
RWD. The leadership activities proposed herein will provide me with an excellent opportunity to transition my
current R01 into a larger NIH-funded program that leverages UF’s extensive RWD resources. Ultimately, this
training will equip me with the skills to lead multidisciplinary teams, develop strategic leadership abilities, and
establish a nationally recognized research program in sleep and Alzheimer’s disease using RWD.

Public health relevance
PROJECT NARRATIVE The use of glucagon-like peptide-1 receptor agonists (GLP-1 RAs) has grown in just the past few years, and there is now compelling evidence to suggest the agents may be effective in treating sleep apnea, a condition known to increase the risk for Alzheimer’s disease and related dementias. This project will investigate the impact of GLP-1 RAs on cognitive outcomes and explore any differences in this association by sleep apnea status. The study has the potential to generate knowledge that will help us determine effective treatment protocols for sleep apnea to improve cognitive health in later life.